Gendered Situated Vulnerabilities and Mental Health among Transgender Men in India

Project Summary
Transgender health research has historically focused on transgender women, yet where data are available,
transgender men and transmasculine persons (TM) demonstrate similar or higher mental health burden. In low
and middle-income countries, however, mental health among TM remains almost entirely unresearched. A
2019 systematic review revealed no scientific publications on TM mental health in India, a country that
accounts for 15% of the global burden of mental disorders and where the transgender community is
experiencing major socio-legal changes that may impact mental health. To fill this critical gap, a mixed-
methods study of TM mental health is proposed, including the first quantitative survey of TM in South Asia.
This study introduces a novel Transmasculine Gendered Situated Vulnerabilities framework which integrates
gender-based analysis with a minority stress perspective to understand the mental health effects of
vulnerabilities and resiliencies related to gender identity as well as assigned sex, situated within the Indian
socio-cultural context. Applying a community-based participatory research approach and a sequential (QUAL
 QUANT) mixed-methods design, 30 TM will be qualitatively interviewed (15 in Delhi and 15 in Mumbai,
India's largest cities) and 300 TM (150 per city) will be recruited to a quantitative survey using online and in-
person approaches. The specific aims are to:
1. Using qualitative methods, identify gendered situated vulnerabilities and resiliencies experienced by Indian
TM and explore perceived mental health impacts and recommendations for interventions.
2. Develop, adapt, and psychometrically assess measures of vulnerabilities (e.g., family rejection and violence)
and resiliencies (e.g., community connectedness, family acceptance), for Indian TM.
3. Quantify mental health challenges (depression, anxiety, self-injury, suicidality) among Indian TM and
evaluate associations with gendered situated vulnerabilities and multi-level resiliencies.
To inform future research and interventions with this population, survey data will also be used to compare the
effectiveness of online versus in-person recruitment strategies. The significance of this timely study lies in the
identification of multi-level factors associated with mental health among Indian TM, with the potential to impact
rapidly evolving transgender health and social policies in India and beyond. The proposed research applies an
innovative theoretical framework to “put the gender back into transgender health”. Expected outcomes include
the development of new measures reflecting family experiences of TM, with applications for global and U.S.
transgender health research. Study results will inform the development and evaluation of an intervention to
promote mental health for TM in India (R34/R01).

Public health relevance
Narrative The proposed study will use mixed methods to characterize mental health among transgender men in India and to identify risk and protective factors in this health disparity population, in alignment with NIH/NIMH priorities. The study will inform future development of mental health interventions by this team and others. An additional benefit of the proposed research is that it will develop and evaluate culturally relevant measures, with potential applications globally and with racially/ethnically diverse transgender populations in the United States, for whom methodological development is an NIH priority.